Precision Prostate Cancer Screening with Genetically Adjusted Prostate-Specific Antigen Levels

Abstract
Prostate-specific antigen (PSA) screening is controversial because it can lead to overdiagnosis and
overtreatment of prostate cancer when individuals have high PSA levels for reasons other than aggressive
disease. It is thus important to ask the question how PSA screening can be improved. Preliminary evidence from
our team suggests that the incorporation of genetic factors into PSA screening decisions has tremendous
potential. During the initial funding period of this project, we have had great success showing that accounting for
genetic factors that impact constitutive, non-cancer PSA levels results in a test that ascertains more clinically
relevant, aggressive disease. In parallel, we have shown that genetic factors for PSA can also be used to improve
polygenic risk scores (PRS) for prostate cancer. Existing PRS are strongly predictive of prostate cancer risk, but
they do not specifically predict aggressive disease because they were largely developed in men with PSA screen-
detected, lower-risk disease. We have initial results demonstrating that removing PSA genetic factors from
prostate cancer PRS makes the PRS more predictive of aggressive disease. Additional studies are needed to
clarify how best to adjust for PSA genetics to improve screening, to develop a prostate cancer PRS that is even
more predictive of aggressive disease by removing additional PSA variants, and to assess the clinical utility of
these tools. In this renewal, we propose to tackle these outstanding imperatives with a comprehensive project
leveraging data from 13 studies ranging from large-scale biobanks to unique clinical populations (N > 500K). In
Aim 1, we will further advance our understanding of PSA genetics by identifying novel rare and common PSA
variants and undertaking functional studies of epigenomic features and single-cell expression quantitative loci.
We will then use this information to develop more accurate and personalized genetic adjustment of PSA levels.
In Aim 2, we will develop a new PRS for prostate cancer aggressiveness by filtering out PC risk variants that are
also associated with non-cancer PSA. We will first remove PSA variants from the prostate cancer PRS based
on statistical significance. Then we will develop and apply a novel hierarchical modeling genome-wide approach
that incorporates PSA associations and functional information. In Aim 3, we will determine the clinical utility of
incorporating genetically adjusted PSA levels and the PRS for aggressive prostate cancer into validated risk
calculators for biopsy outcomes (higher grade disease) and prostate cancer active surveillance upgrading. We
will also investigate the relationships between genetically adjusted PSA, the aggressive prostate cancer PRS,
and lethal prostate cancer. These models will allow us to assess the benefit of incorporating genetic information
into decisions about frequency of screening, escalation to prostate biopsy, and selection of active surveillance
following diagnosis. Our renewal aims in aggregate are promising toward reducing PSA screening harms while
improving screening benefits and predicting risk of clinically important disease. In translation, clinicians and
patients could make more informed decisions, reducing unnecessary procedures and improving outcomes.

Public health relevance
Project Narrative Prostate-specific antigen (PSA) screening results in substantial overdiagnosis and overtreatment of prostate cancer, and existing polygenic risk scores for prostate cancer do not do a good job of predicting disease aggressiveness. The goals of this renewal are to improve the PSA screening test by incorporating genetic information and to develop a polygenic risk score predictive of aggressive prostate cancer. We will then evaluate the clinical utility of these developments in prostate cancer risk calculators and for lethal disease.